Modeling mechanisms in cytokinesis, cell polarization and motility

Project Summary/Abstract
The ability of cells to divide, establish a polarization direction, and move by crawling requires the coordinated
interactions of the cytoskeleton with membranes as well as with the signaling system organizing on
membranes. A major challenge for the development of predictive mathematical and computational models of
these mechanisms of subcellular organization is accounting of how highly specific interactions at the molecular
level lead to the emergent collective behavior. We address this complexity by employing computational and
mathematical modeling methods linking molecular to cellular scales, in close collaboration with
experimentalists working on model systems that reveal important cell biological functions and are amenable to
quantitative approaches. We have three areas of current focus. (1) Understanding the molecular mechanisms
and biophysical principles governing the nanoscale assembly of fission yeast nodes, which orchestrate cell
cycle progression and cytokinesis. A multiscale approach, combining computational modeling techniques with
experiments by collaborators will investigate the interactions among node proteins and the membrane,
focusing on Cdc15, Mid1, and Cdr2. Key questions regarding node assembly, phosphorylation regulation, and
nuclear shuttling will be addressed. (2) Modeling of membrane hydrodynamics and mechanics during fission
yeast cytokinesis and its coupling to the spatial distribution of exocytosis and endocytosis. Coarse-grained fluid
simulations will be tested against experiments with vesicle traffic mutants. We will investigate flow-induced
transport of membrane proteins and its implications for the membrane and cytoskeleton. (3) Understanding
force generation by dendritic networks in the presence of myosin I, the significance of severed oligomers in
cellular actin transport, and the interaction for the actin cytoskeleton with focal adhesions and the extracellular
matrix. Mathematical models will be developed at the level of individual actin filaments, oligomers, and talin
linkers. Overall, the research integrates computer simulations, experimental observations, and collaborative
expertise to deepen our understanding of actin and membrane dynamics and its implications for cellular
behavior.

Public health relevance
Project Narrative We will study the biophysical and biological mechanisms involved in cell division, cell growth and movement, important for organism development, differentiation, neuron function, or cancer cell metastasis. To address the complexity of cellular dynamics, the project combines mathematical modeling with experimental studies by collaborators. If successful, this basic science would underpin future medical research based on an understanding of cellular function.